Identifying the Determinants of Persister Cell Survival in M. tuberculosis.

PROJECT SUMMARY / ABSTRACT
Mycobacterium tuberculosis (Mtb) remains a threat to human health, and treatment of
tuberculosis (TB) is arduous, requiring multiple, potentially toxic antibiotics administered for 4
months or more. Thus, there remains a critical need to understand the mechanisms enabling
Mtb to survive prolonged exposure to lethal antibiotics. Mtb, like many bacteria, has the ability to
form antibiotic persister cells ,which can survive for prolonged when exposed to bactericidal
antibiotics. The goal of this proposal is to apply a combination of genetic and proteomic
approaches to identify the key pathways enabling the survival of antibiotic persister cells in Mtb.
In Aim 1 we propose to rigorously identify the genetic determinants of persister cells to identify
genes needed for persister cell formation in multiple contexts, enabling an identification of core
pathways contributing to persistence across multiple contexts. In Aim 2 we will use proteomics
to define the signaling events associated with persister formation which will help both to
prioritize factors studied in vivo, and to form clear biochemical hypotheses. If successful, these
studies would provide insights that could be leveraged therapeutically to develop “persistence
inhibitors” that act cooperatively with traditional antibiotics to hasten Mtb eradication in patients.

Public health relevance
PROJECT NARRATIVE This project seeks to understand how Mycobacterium tuberculosis escapes antibiotic lethality. Understanding the underlying biology is critical in the development of new treatment approaches aimed at more rapidly eradicating infection in tuberculosis patients.